PLASMA EXCHANGE IN SEVERE DEMYELINATING DISEASE

The purpose of this study is to determine whether plasma exchange is effective in reversing the neurological injury in patients with acute, severe inflammatory demyelinating disease.